Reimagining the IMAGINE-TBM trial: Using metagenomics and host transcriptomics to improve our ability to diagnose tuberculous meningitis and assess response to treatment in a randomized clinical trial

PROJECT SUMMARY
Tuberculous meningitis (TBM) is one of the most devastating forms of tuberculosis (TB), with mortality rates as
high as 50%. Despite dismal outcomes, few data are available on optimizing the approach to treatment of
TBM. While several interventional TBM trials are underway, they face tremendous barriers that could impede
the knowledge gained from these essential studies. First, TBM is exceptionally difficult to diagnose, which
directly impacts selection of the right trial population on which to test treatment regimens. Second, although the
host immune response may be a major driver of poor outcomes in TBM, our understanding of the
immunopathogenesis of TBM and how it may be targeted with host-directed therapy is in its infancy. Third,
dedicated resources to develop and sustain research capacity are often limited in low- and middle-income
countries (LMIC) where TB is endemic and where data-driven treatment strategies for TBM are urgently
needed. In this ancillary study, we propose 3 scientific aims and a capacity-building plan designed to address
these major challenges. We will perform a secondary analysis of the ACTG IMAGINE-TBM (Improved
Management with Antimicrobial AGents Isoniazid rifampiciN LinEzolid for TBM) trial, a phase II randomized
trial comparing a 6-month regimen of high dose rifampin, high dose isoniazid, linezolid, and pyrazinamide with
a 9-month standard of care regimen in participants at 17 sites in 12 LMIC across 3 continents. In Aim 1, before
deploying our previously developed host transcriptomic machine learning classifier (MLC) to diagnose TBM in
the diverse IMAGINE-TBM trial population, we will use integrated host gene expression data from stored
cerebrospinal fluid (CSF) from two successfully completed TBM trials, TBM-KIDS and ALTER, to retrain and
revalidate the MLC. In Aim 2, we will use a combination of direct pathogen detection with CSF metagenomic
next generation sequencing (mNGS) and the optimized host transcriptomic MLC developed in Aim 1 to
reclassify 300 IMAGINE-TBM participants as definite versus not definite TBM, after which we will re-analyze
the efficacy of the investigational regimen versus standard of care. In Aim 3, we will use a case-control study
design nested within IMAGINE-TBM to determine if host gene expression profiles differ between participants
who have a poor versus good outcome. This study will leverage stored biologic specimens and existing data to
augment the knowledge gained from IMAGINE-TBM. By re-analyzing the trial after re-classifying participants
using mNGS and host transcriptomics, we could detect a benefit of the investigational regimen that would
otherwise be missed. In addition, findings from the study will provide critical insights into immune pathways
implicated in TBM pathogenesis and response to treatment, which could support the use of targeted host-
directed therapies. In conjunction with the scientific aims, to strengthen capacity for sustainable TBM research
programs based in epicenters of the TB epidemic, we will partner with the Chan Zuckerberg Biohub to support
training in metagenomics and bioinformatics at 3 regional training hubs in India, Kenya, and Peru.

Public health relevance
PROJECT NARRATIVE Tuberculous meningitis (TBM) is a devastating form of tuberculosis (TB) with high rates of mortality and disability. This ancillary study will use metagenomic, transcriptomic, and bioinformatics tools to augment the knowledge gained from a randomized controlled trial of an investigational treatment regimen on functional outcomes and mortality in patients with TBM. In parallel with the scientific goals of the study, we will develop and strengthen capacity at 3 regional training hubs in India, Kenya, and Peru local research aimed at improving outcomes in TBM. to apply these tools to advance